Alveolar Macrophage Iron Overload in COPD Pathogenesis

PROJECT SUMMARY
Chronic obstructive pulmonary disease (COPD) is a smoking-associated respiratory disease and is the 3rd lead-
ing cause of death worldwide. There are increased numbers of dysfunctional airway and alveolar macrophages
(AMs) in the lungs of smokers and COPD patients, localizing to areas of injury. Despite this connection, the
mechanisms behind how cigarette smoke (CS) elicits AM dysfunction, and how AM dysfunction facilitates the
development of small airways disease and emphysema, two defining features of COPD, are poorly understood.
This proposal addresses this critical gap in knowledge and tests the hypothesis that AM dysfunction in COPD is
mechanistically linked to abnormal iron accumulation in these cells. Using a multicenter prospective COPD
(SPIROMICS) cohort, we previously associated increased levels of iron and iron-related proteins in the bron-
choalveolar lavage fluid of smokers and COPD patients with adverse clinical COPD outcomes. AMs are the
putative source for this lung extracellular iron, as AMs from smokers and COPD patients are iron-overloaded
and release iron in culture. We replicated this clinical phenomenon of AM iron accumulation and release using
a murine CS-exposure model. We then used single-cell RNA sequencing and discovered novel AM subsets
which have a unique iron-related gene expression signature that is consistent with increased iron uptake. These
“iron macrophages”, which we designate as FeMacs, have decreased expression of genes associated with
phagocytosis and immune activation, suggesting that this CS-induced AM iron accumulation may have functional
consequences for AMs, and potentially for the CS-exposed lung. We will test our hypothesis that FeMacs or-
chestrate lung injury development in COPD both mechanistically using our murine CS model and translationally
using the SPIROMICS cohort. Aim 1 will compare CS-induced small airways damage and emphysema develop-
ment between control mice and mice with AMs deficient in nuclear receptor coactivator 4 (Ncoa4ΔCd11c), an iron
metabolism defect which mitigates CS-induced iron accumulation. Aim 2 examines Ncoa4ΔCd11c and Ncoa4fl/fl
control mice in a CS-Streptococcus pneumoniae infection 2-hit model, thereby determining whether reducing
AM iron overload can alleviate CS-induced AM dysfunction and improve response to pathogen. Aim 3 defines
the clinical relevance of AM iron accumulation in human COPD and tests AM expression of iron genes and AM
iron content as markers of COPD severity. This proposal presents a five-year career development plan that
builds on my previous research and integrates the different domains of expertise of my mentorship and advisory
teams. It entails a targeted training plan that is tailored towards the development of specific areas related to
immunology, macrophage biology, iron biology, and translational research, facilitated by the physical and intel-
lectual resources provided by the academic environment at Weill Cornell Medicine. The proposed experiments,
didactic training, as well as mentorship team will position me with a unique set of interdisciplinary skills that will
enable my transition to independence as a physician-scientist in lung and macrophage biology and iron biology.

Public health relevance
PROJECT NARRATIVE Although cigarette smoke exposure is the leading risk factor for the development of chronic obstructive pulmo- nary disease (COPD), how smoke causes progressive lung damage in COPD is poorly understood. Our prelim- inary data suggest that the abnormal accumulation of iron in alveolar macrophages, sentinel immune cells in the lung, may be a critical link between smoke and its downstream detrimental effects. In this proposal, we will develop and confirm this biological connection between iron, alveolar macrophages, and COPD development using a mouse smoke-exposure model and an extensively characterized multicenter COPD cohort, with the goal of building evidence to eventually develop therapy targeting iron in COPD.